Clinical Trials Network Mid-Atlantic Collaborative Group

DESCRIPTION (provided by applicant): The Mid Atlantic Node was among the first participants in the National Drug Abuse Treatment Clinical Trials Network. It's Regional Research and Training Center (RRTC) is comprised of distinguished faculty from Johns Hopkins University School of Medicine, Virginia Commonwealth University and Friends Research Institute as well as directors of affiliated community treatment programs (CTP's). This partnership between researchers and clinical service providers has been functioning effectively over the past 10 years and has allowed the Node to make substantial contributions to the CTN including leadership of two studies, and participation in 7 additional studies with 601 subjects enrolled during the last 5-year funding period. Importantly, the Node has an outstanding record of publication productivity with 24 publications reporting on CTN main study findings, ancillary studies and secondary analyses and supports the Chair of the CTN Publications Committee. In the upcoming grant period, the Node will maintain collaboration with VCU while expanding its affiliation with Friends Research Institute. This will bring additional faculty expertise and infrastructure support into the Node including expertise in medications development (e.g. Frank Vocci) and criminal justice research (Timothy Kinlock). We have formed broader affiliations at VCU with the Women's Health Institute (Susan Kornstein), the Institute for Drug Addiction Science (Robert Balster) and the Institute for Genetics Research (Kenneth Kendler). At Johns Hopkins, we have expanded faculty affiliates to bring in additional expertise in clinical trials, contingency management, cognitive testing, and marijuana research. We have established affiliations with the Hopkins Department of Emergency Medicine, with the School of Dentistry at University of Maryland and with the Johns Hopkins Institute for Clinical Translational Research (ICTR). Finally, we have added CTP's, including the Whitman Walker Clinic in Washington DC, that incorporate primary care, HIV care and co-occurring mental health disorders in their scope of service and a new clinic (Richmond Behavioral Health) with extensive experience in community participatory research. All these new affiliations will help the Node to meet short- and long-term expansion in the mission of CTN and to participate in a wide variety of studies that are likely to be developed. Finally, the Node will continue its strong dissemination activities that provide significant benefit to affiliated CTP's while promoting adoption of evidence-based practices.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Mid Atlantic Node is part of a national multi-site clinical trials network supported by the National Institute on Drug Abuse. Mission of the network is to conduct research at community treatment programs that will identify effective therapies for treatment of drug users. Subsequent adoption of new effective treatments by community programs will improve the quality of drug abuse treatment nationwide. __SpecificAimsTextDelimiter__ The CTN was established in 1999 following publication of a report (Lamb et al.. 1998) that highlighted the gap between research and practice in drug abuse treatment. This gap was a problem since the point of drug abuse treatment research is to develop and test new and better treatment interventions, while the goal of treatment providers is to deliver the best possible quality of care. The relative dearth of cross-fertilization between the two areas of expertise operated as a barrier to adoption of new and potentially more effective treatment approaches. The overarching mission of CTN was to bridge that research-to-practice gap by 1) establishing a bi-directional partnership between research groups at major universities and community-based treatment providers (CTP's), with care providers having an equal place at the table in decision-making, 2) conduct multi-site clinical trials at community settings to test effectiveness of promising treatment interventions and 3) promote dissemination of research findings and adoption of new evidence-based practices by community programs. Science is the vehicle through which the CTN can advance understanding about the nature of drug dependence, about the process of recovery and about best treatment practices that will facilitate improved quality of care for drug abuse nationwide. The CTN has been enormously successful in the 10 years of its existence. Strong bi-directional partnerships have been formed in an array of regionally diverse settings. Over 30 studies have been conceived and conducted, and several effective clinical practices have been identified and disseminated including buprenorphine treatment for adults (Ling et al., 2005) and adolescents (Woody et al., 2008), motivational interviewing as an eariy engagement strategy (Carroll et al., 2006a), motivational incentives for reducing during-treatment drug use (Peirce et al., 2006) and prolonging drug-free treatment participation (Petry et al., 2005) and treatments to reduce risky sexual behavior and consequent HIV exposure among drug users (Calsyn et al., 2009; Tross et al., 2008) (see ctndisseminationlibrary.org for listing of 130 papers published from CTN research). The Mid Atiantic Node of the National Drug Abuse Treatment Clinical Trials Network (CTN) has been participating as a successful contributor since inception of the CTN project in 1999. The Node has led two national multi-site studies and participated in a number of studies led by others. It has had a bi-institutional collaboration with Virginia Commonwealth University and is thus an exemplar of inter-institutional collaboration. The Node maintains close collaborative relationships with a long-standing group of CTP's in both Baltimore and Virginia who have made numerous contributions to the project both locally and nationally. Finally, the Node has been able to adapt to changes in CTN organization and infrastructure to create and sustain an efficient administrative and research support core. In this competing continuation, we aim to further adapt the Node to accommodate an expanded vision of the CTN. This includes collaborations with more diverse institutional settings, including primary care settings, and establishing relationships with an expanded array of faculty expertise that may be needed to envision and develop CTN research protocols in the future. We enter the competing renewal period with the following eight specific aims: Mid Atiantic Node 1. Broaden affiliated treatment provider base 2. Broaden affiliated faculty expertise 3. Broaden organizational affiliations 4. Continue bi-directional concept development 5. Continue active clinical trials participation 6. Continue high rate of research publication 7. Continue active service to CTN 8. Expand training and research dissemination activities Maryland Virginia Washington DC As supported in this application, the Mid Atiantic Node is in a strong position to accomplish these important aims. In doing so, the Node will continue its substantive contribution to the overarching mission and goals of the National Drug Abuse Treatment Clinical Trials Network, a contribution that has been continuously apparent throughout the history of this unique and important Clinical Trials Network center within the National Institute on Drug Abuse. 148stitzer, Maxine L. et al. Mid Atiantic Node